Esx5 secretome in TB and TB-HIV pathogenesis and immunity

PROJECT SUMMARY
Mycobacterium tuberculosis, the causative agent of human TB, lives exclusively in human cells, and to
understand how it causes disease it is important to determine how it delivers its key pathogenic proteins into
cells. Using specialized transduction, we generated the only reported complete genetic deletion of the esx5
locus encoding a transport system that is thought to secrete ~150 proteins out of the microbe, and we found
that this esx5 mutant is a remarkably good live attenuated vaccine for preventing TB in animal models. In this
study we will use our novel esx5 mutant to identify the specific proteins which it secretes, characterize the roles
of these secreted proteins in causing disease, and determine the immunologic basis for why the mutant is such
a good vaccine.

Public health relevance
PROJECT NARRATIVE This is an MPI grant (Jacobs, Bishai) to characterize the Esx5 secretome of Mycobacterium tuberculosis (Mtb) and BCG. Mtb possesses five Type 7 secretion systems (T7SSs) known as Esx1-Esx5. These T7SSs deliver proteins from the cytosol to the periplasmic space of Mtb. An important unanswered question in mycobacterial physiology is how cargo tranverses the outer mycomembrane (OMM) which is complex bilayer comprised of long chain lipids such as mycolic acids. The Esx5 system is the most recent evolutionarily, and it is uniquely present in pathogenic mycobacteria. It is believed that ~150-170 proteins are transported by Esx5 and that many of its substrates belong to the PE, PPE, and PE-PGRS protein family which contain repetitive Pro-Glu stretches and are also uniquely abundant in pathogenic mycobacteria. An unmet need in the TB field is to define the Esx5 secretome (eg, the protein substrates of Esx5) comprehensively. Another unmet need is to elucidate the functional roles of the PE, PPE, and PE-PGRS protein family—the likely substrates of Esx5. Two leading postulates are that PE and PPE proteins comprise (i) secreted virulence effectors or (ii) OMM channels; indeed, in support of the second, the PE19-PPE51 dimeric pair has been shown to transport small carbon substrates across the OMM. The esx5 locus was thought by many to be an essential genetic locus, as numerous labs have attempted to knock it out unsuccessfully. A unique strength of this proposal is that we have recently generated a full-locus deletion of esx5. This esx5 mutant is attenuated for growth in broth (requires supplemental nutrients and still has a slow doubling time) and highly attenuated in animals. We have developed methods to purify the culture filtrate proteins and OMM proteins of Mtb without cytosolic contamination, and have performed quantitative proteomics on the Esx5 mutant compared to WT Mtb. These studies have enabled us to identify 28 high probability Esx5 secretome candidates and another 49 likely candidates. These studies also revealed the surprising finding that the esx5 mutant is broadly deficient in OMM proteins suggesting that Esx5 is the major transporter of OMM proteins. We have found that the ∆esx5 mutant is a potent live attenuated vaccine, and that the prime/boost combination of BCG/esx5 is significantly better in TB prevention in mice and guinea pigs than BCG alone. In this application, we propose to utilize the ∆esx5 mutant to complete a comprehensive catalogue of the Esx5 secretome for both the OMM and CF compartments (Aim 1). We also seek to determine which members of the Esx5 secretome play roles in Mtb virulence (Aim 2) and immune protection when the ∆esx5 mutant is used as live attenuated vaccine (Aim 3).